Connecticut MFRPS, FPTF and Special Project Grant

State Flexible Funding Model - Infrastructure Development and Maintenance for
Connecticut’s Manufactured Food Regulatory Programs
FOA: RFA-FD-18-001
CFDA: 93.367
Connecticut Department of Consumer Protection
Project Summary
Project Summary
The Connecticut Department of Consumer Protection has developed this proposal to advance efforts in
Connecticut so as to be in concert with the nationally integrated food safety system (IFSS). This will be
accomplished by pursuing continued maintenance support for five years of Manufactured Food
Regulatory Program Standards (MFRPS) in Connecticut, applying for the development and continued
funding for five years of a Food Protection Task Force (FPTF) in Connecticut and for a five year special
project related to education/outreach on food labeling.
The Project Goals for the CT MFRPS Program are to achieve and maintain conformance with the most
recent version of the Standards, contribute to the continuous improvement of the MFRPS through
attendance at an annual face-to-face meeting, active participation in committees, other initiatives, and
develop strategies and resources for achieving and maintaining conformance with the Standards that
can be shared and duplicated on a national basis, and provide FDA the foundation for pursuing
regulatory action based upon the findings of State manufactured food regulatory programs. Connecticut
will also provide FDA the foundation to improve quality of contracts, coordination of inspections,
investigations and enforcement to effectively and efficiently protect public health.
The Food Protection Task Force and Special Project on Packaging and Labeling will also support the IFSS
and FSMA.

Public health relevance
FOA: RFA-FD-18-001 CFDA: 93.367 Connecticut Department of Consumer Protection Project Narrative Project Narrative Our plan is to continue the work related to the Manufactured Food Regulatory Program Standards, building on previous successes that professionalizes Connecticut’s food safety work force in Consumer Protection and supports the Integrated Food Safety System. To accomplish these goals we are working to see that our team is properly trained and supported, as we work with our lab partners, state and federal partners to ensure that Connecticut citizens have safe food. We are also working to actively support our federal partners in their goals, through contract work and by supporting initiatives and the standards to promote public health through safe food and by referral of actionable enforcement initiatives.